Inference in Regression Models with Missing Covariates

In this proposal, we propose Bayesian and frequentist methodology for local influence diagnostics and develop model assessment tools for complete data settings as well as in the presence of missing covariate and/or response data for a variety of statistical models, including generalized linear models, models for longitudinal data, and survival model. In Specific Aim 1, we develop frequentist local influence measures and goodness of fit statistics based on the general local influence development of Cook (1986), and discuss these measures for i) linear models with missing at random (MAR) and nonignorably missing covariates and ii) generalized linear models with MAR and nonignorably missing covariates. For Specific Aim 2, we develop new classes of Bayesian case influence diagnostics for the complete data setting then generalize these diagnostics to the missing data framework. The proposed methodologies in Aims 1-2 are primarily motivated from several studies in the PI's collaborative work.

Public health relevance
Project Narrative We propose Bayesian and frequentist methodology for local and case influence diagnostics and develop model assessment tools for complete data settings as well as in the presence of missing covariate and/or response data for a variety of statistical models, including generalized linear models, models for longitudinal data, and survival models. The proposed methodology is very useful in applications involving chronic diseases, such as cancer and AIDS.